LONGITUDINAL ASSOCIATION OF POST-INFARCT LIPOMATOUS METAPLASIA AND MALIGNANT ARRHYTHMIA

Myocardial infarction (MI) from coronary artery obstruction affects more than 1 million people annually in the
United States resulting in symptoms, reduced quality of life, and substantially increased risk of heart failure and
sudden death. Rapid diagnosis on electrocardiography and treatment with percutaneous intervention (PCI) are
essential to minimize the risk and size of permanent myocardial injury as well as the risks of ischemia or
reperfusion triggered malignant arrhythmia. Ironically, restoration of blood flow to infarcting myocardium can
result in reperfusion injury and expand infarct size. Recent data from animal studies suggest that reperfusion
injury may promote lipomatous metaplasia (LM) or intra-myocardial fat deposition. LM has been shown to
associate with negative cardiac remodeling, leading to worsening heart function and higher chances for
congestive heart failure. We have shown that LM is prevalent but highly variable in distribution among patients
with prior MI and ubiquitous among those presenting with ventricular tachycardia (VT). We have also shown
that corridors critical to VT circuitry traverse infarcted tissue through or near LM. The latter association appears
to be mediated by prolonged local action potential duration, reduced conduction velocity, as well as increased
regional resistance and reduced current loss as impulses traverse corridors adjacent to LM. In prior studies, we
have also shown that reperfusion injury, the apparent precursor to LM, can be quantified by cardiac magnetic
resonance (CMR) as pathologic iron deposition, and is present in most patients despite nominally successful
reperfusion. However, the association of reperfusion injury with LM incidence and progression in humans have
not yet been defined. Additionally, no prospective study has evaluated the longitudinal evolution of scar, LM,
and viable tissue architecture with the incidence of VT. Thus, we propose a prospective observational study of
175 patients <2 months since PCI for acute ST elevation MI (STEMI) that undergo CMR at baseline, and at 1-
and 2-years’ follow-up. Using data from this cohort we will test the following premises: 1. That LM incidence
occurs early post STEMI and that its volumetric progression is associated with time since reperfusion; 2. That
the extent of LM is associated with reperfusion injury following PCI for STEMI; and 3. That LM precedes and
predicts the incidence of sustained VT following MI. Our group has extensive experience with STEMI and VT
management, image acquisition and analysis, epidemiology, and biostatistics. The findings of this study will
have wide applicability to our mechanistic understanding and management of cardiac remodeling and VT.

Public health relevance
Of the 1 million people in the US that will develop myocardial infarction (MI) this year 25-50% will be susceptible to sudden death due to malignant arrhythmia over their lifetime. Many strategies are available to mitigate the risk of arrhythmia, and mortality; however, the underlying factors that attenuate individual risks are poorly informed by currently available data. The proposed prospective observational study will define the longitudinal association of reperfusion injury after percutaneous intervention for MI with intra-myocardial fat deposition, negative cardiac remodeling, and malignant arrhythmia.